Early Adolescents Polysubstance Use Patterns: Longitudinal Changes and Bidirectional Relations with Externalizing Behaviors

PROJECT SUMMARY
Substance use during early adolescence is associated with a variety of adverse outcomes. Early adolescents
often initiate use of more than one substance (i.e., polysubstance use), which increases their risk for negative
outcomes, including adult substance use disorders, mental health disorders, and social and legal problems.
However, few studies have identified patterns of polysubstance use among early adolescents. There is a
critical gap in knowledge of how polysubstance use develops during early adolescence and risk and protective
factors for polysubstance use. There is clear evidence that early adolescents’ substance use co-occurs with
externalizing behaviors, including physical aggression and delinquent behavior. What is less clear is the extent
to which engaging in externalizing behaviors predicts subsequent changes in substance use, or whether
substance use predicts changes in externalizing behaviors. Moreover, few studies have tested theoretical
mechanisms that may explain these relations. The goal of the proposed study is to address limitations of prior
research by identifying subgroups representing patterns of early adolescents’ polysubstance use, establishing
their transitions over time, and examining their concurrent and longitudinal bidirectional relations with physical
aggression and delinquency. The proposed study will also explore peer and caregiver factors as potential
mediators of these relations. These goals align with NIDA’s goal of identifying causes and consequences of
substance use, and priority focus (Theme 3) of addressing real-world complexities of substance use, including
polydrug use and co-occurring health conditions. The aims will be addressed through analysis of 4 waves of
data that were collected every 3 months from a primarily African American sample of 2,755 early adolescents
living in urban communities with high rates of poverty and violence. Latent transition analysis and longitudinal
cross-lagged structural equation models will be used to examine changes over time. The specific aims are to:
1) Examine longitudinal changes in polysubstance use patterns within and across all three middle school
grades, 2) Evaluate concurrent and longitudinal bidirectional relations between physical aggression and
delinquency and polysubstance use patterns, and 3) Explore peer delinquency and caregiver knowledge as
mediators or predictors of adolescents’ externalizing and substance use behaviors over time. Differences
across sex and grade will be examined for each aim. The findings will inform prevention efforts by refining our
understanding of risk for early polysubstance use, potentially highlighting optimal intervention periods, and
identifying possible intervention targets. Moreover, the research and training outlined in this NRSA F31 pre-
doctoral fellowship application will equip the applicant with skills and mentoring needed to pursue an
independent research career, including knowledge of factors that impact adolescents’ substance use,
competences in advanced longitudinal statistical methods, and professional skills related to scientific writing
and dissemination.

Public health relevance
PROJECT NARRATIVE Polysubstance use during early adolescence is associated with elevated risk for social, legal, and health concerns, including development of substance use disorders, and co-occurs with other problem behaviors such as physical aggression and delinquent behavior. The proposed project examines changes in polysubstance use patterns among middle school students, the extent to which physical aggression and delinquent behavior predict escalation in polysubstance use over time, and explores whether peer and caregiver factors explain these relations. The results will guide prevention and intervention efforts by identifying polysubstance use patterns and their associations with other problem behaviors during early adolescence, a high-risk period for substance use initiation and escalation.